HMGB1 and innate immune involvement in adult neuropathology following adolescent alcohol exposure

Abstract.
This is a revised application for a Mentored Research Scientist Development Award (K01) to support the
career development of Dr. Ryan Vetreno as an independent academic research scientist in the field of alcohol
research. The applicant’s career and research training will be supervised by an outstanding mentoring team
and supported by strong institutional commitment to the candidates’ career development. Humans typically
begin drinking during adolescence when the brain is maturing and adolescent drinking behavior is
characterized by the consumption of large quantities of alcohol in a heavy binge-like intermittent fashion (e.g.,
weekend drinking). Preclinical models of adolescent binge drinking reveal persistent reductions of basal
forebrain cholinergic neurons, diminished hippocampal excitatory neurotransmission, and impaired reversal
learning in adulthood. Using the adolescent intermittent ethanol (AIE) model of human adolescent binge
drinking, Dr. Vetreno discovered increased expression of the innate immune receptor Toll-like receptor 4
(TLR4), the endogenous TLR4 agonist high-mobility group box 1 (HMGB1), and multiple proinflammatory
signaling molecules that persist in the adult brain. The causal relationship between AIE-induced HMGB1-TLR4
innate immune induction and subsequent adult neuropathology is unknown. In his revised application, Dr.
Vetreno proposes to test the mechanistic hypothesis that AIE induction of HMGB1-TLR4 signaling causes
degeneration of adolescent basal forebrain cholinergic neurons leading to hippocampal dysfunction in
adulthood. In order to fully test this hypothesis, Dr. Vetreno and his Mentors have devised a comprehensive
mentoring and research plan that will provide him with protected time for intensive training in ex vivo slice
culture, electrophysiology, and chemogenetics. The training outlined in this proposal will provide the candidate
the means to develop a successful, independent research laboratory at the University of North Carolina at
Chapel Hill that will be at the forefront of adolescent alcohol and neuroimmune research. Together, these
studies will advance our understanding of the mechanisms underlying persistent changes to adolescent brain
development associated with underage binge drinking, provide innovative targets for the development of
therapeutic interventions, and will markedly advance Dr. Vetreno’s career development and scientific
independence.

Public health relevance
Project Narrative. Adolescent alcohol use and abuse is a major public health concern that has a long-lasting impact on health care in the U.S. Adolescent binge drinking persistently activates the innate immune system in brain that might disrupt adolescent brain maturation. It is imperative that the effects of alcohol on the adolescent innate immune system be fully investigated, with the goal of developing therapeutics aimed at treating the neurodegeneration associated with adolescent binge drinking as well as alcoholism.